Ameliorating off-target toxicities of CAR T cells by engineering NOT gates

Project Summary/Abstract
Engineered therapeutic T cells have shown transformative success in treating B cell cancers but applying this
approach to solid tumors has proven far more difficult. There do not appear to be absolutely tumor-specific single
antigen targets for solid cancers, and thus, CAR T cells that attack most tumor-associated antigens have led to
toxic cross-reaction with normal organs that also express the antigen. If we are to successfully and safely treat
solid tumors with CAR T cells, it will be essential to mitigate toxic cross-reaction with normal tissues.
To prevent off-tumor toxicity of therapeutic T cells, we propose to engineer multi-receptor T cell circuits that can
recognize a tumor based on a multi-antigen profile. In this proposal, we focus specifically on engineering NOT
gate circuits -- circuits that can override and inhibit CAR T cell activation and killing upon detecting an antigen
that is uniquely indicative of a cross-reactive normal tissue (i.e., antigen is absent in the tumor). Our recently
published bioinformatic analysis shows that there are numerous tissue-specific antigens that could be used as
signals to induce T cell inactivation in common cross-reactive tissues like the brain and lung. Nonetheless, there
is currently a lack of robust NOT-gate circuits demonstrated to work well in tumor models. Thus, we will develop
and test new NOT circuits that can inactivate a CAR T cell in an antigen-induced manner. Our specific aims are:
Aim 1. Engineer, prototype and optimize new NOT gate circuits that use diverse mechanisms to block
therapeutic T cell activation in antigen-induced manner
Aim 1.1. T cell NOT gates using transcriptional repressors of CAR expression.
Aim 1.2. T cell NOT gates that inhibit T cell proliferation by antigen-induction of cell death effectors.
Aim 1.3. T cell NOT gates that locally induce production of secreted immunosuppressive factors (paracrine)
Aim 2. Applying NOT gate circuits to prevent anti-GD2 CAR T cross-reaction with brain/CNS tissue.
Aim 2.1. in vitro prototyping of NOT gate circuit targeting the brain antigen MOG to turn off anti-GD2 CAR
Aim 2.2. Test if brain NOT gates block CNS toxicity of anti-GD2 CAR T cells in vivo, while maintaining
efficacy against murine neuroblastoma xenograft models (GD2+).
Aim 2.3. Test in vivo safety & efficacy of NOT gate CAR T cells in an immunocompetent model of
neuroblastoma.
This work should provide important general capabilities for engineering CAR T cells that selectively turn
themselves OFF when they are in the wrong, cross-reactive tissue. These are much needed tools that are
currently missing in the toolbox for T cell engineering, but which will be critical for engineering T cells that safely
treat solid cancers.

Public health relevance
Project Narrative The goal of this project is to engineer therapeutic immune cells that can clear tumors while minimizing toxicity against healthy tissue.